Mentored Training in Molecular Epidemiology of Chronic Kidney Disease in Diverse Populations

Enter the text here that is the new abstract information for your application.
This section must be no longer than 30 lines of text.
Chronic kidney disease affects one in seven U.S. adults and is a leading cause of death and disability. Chronic kidney disease has a substantial impact on U.S. populations. Research on the epidemiology and molecular risk factors contributing to chronic kidney disease in US populations is much needed to guide public health prevention and interventions, and to develop therapeutic tools for clinicians to effectively treat the disease. This K26 application will support protected time for Nora Franceschini, MD MPH, to mentor junior investigators on molecular epidemiology research of chronic kidney disease. Dr. Franceschini is a nephrologist and an epidemiologist with a 20-year experience conducting multidisciplinary studies in chronic kidney disease and mentoring graduate students and early-stage investigators, including physicians and PhD candidates. Dr. Franceschini has developed a strong National Institutes of Health supported research program on chronic kidney disease at the University of North Carolina focused on global populations. This research program offers multiple opportunities for trainees to learn rigorous research skills in state-of-art approaches for research in the epidemiology, molecular epidemiology and biomarkers of chronic kidney disease. Proposed activities and enhanced mentoring skills support the goals to increase high-quality mentoring for the next generation of scientists in chronic kidney disease research within her research program.

Public health relevance
This proposal addresses a critical need of increasing the US workforce for research in chronic kidney disease, a disease that affects one in seven U.S. adults and has a high impact in public health. The proposed mentoring of trainees and junior investigators focuses on molecular epidemiology research of chronic kidney disease to improve the understanding of disease etiology and risk, and ultimately guide public health prevention and interventions, and develop therapeutic tools for clinicians to effectively treat the disease. The mentoring will be accomplished through activities based on Dr. Franceschini’s extensive research program and the University of North Carolina graduate school.